The role of Hedgehog in hematopoiesis and leukemogenesis

DESCRIPTION (provided by applicant): Hedgehog (Hh) proteins are a highly conserved family of intracellular signaling molecules that play critical roles in normal development, self-renewal, and in the development of several cancers. Therefore Hh antagonists are under development as potential therapeutic agents. We recently reported the unexpected finding that loss of Hh signaling through conditional deletion of Smoothened (Smo) has no apparent effect on adult hematopoietic stem cell function and hematopoiesis, and leukemogensis mediated by MLL-AF9. Furthermore, pharmacologic inhibition of Hh signaling with a selective small molecule antagonist had no substantive effect on hematopoiesis in the mouse (Hofmann et al 2009). In contrast recent reports in the literature indicate that Smo is essential for BCR-ABL mediated leukemia (Dierks et al 2008, Zhao et al. 2009). Based on these observations we hypothesize that leukemia associated alleles that do not themselves engender self-renewal potential to committed hematopoietic progenitors such as BCR-ABL and KRAS require Hh signaling for long-term disease maintenance. In contrast, we hypothesize that leukemogenic alleles that can confer properties of self-renewal to committed progenitors such as MLL-AF9 and CDx2 do not require Hh signaling. To test this hypothesis we propose to express the above leukemogenic alleles in a Smo deficient background and assess impact on development, maintenance, and transplantability of leukemia. Furthermore we will use pharmacologic approaches to evaluate whether inhibition of the Hh pathway leads to inhibition of leukemia progression. The Specific Aims are: 1) To determine if Hh signal transduction is required for leukemic transformation mediated by oncogenes that that do not confer self-renewal potential such as BCR-ABL, and oncogenic KRAS 2) To evaluate whether Hh signaling is dispensable for leukemogenesis mediated by oncogenes that do engender self-renewal potential such as MLL-AF9 and CDX2. 3) To determine whether progression of leukemia induced by BCR-ABL, KRAS or MLL-AF9 can be inhibited by the selective small molecule Hh inhibitor HhAntag in vivo. With support from the K08 Award, Dr. Hofmann Zhang, a Pediatric Hematology/ Oncology instructor at Children's Hospital Boston (CHB) has outlined a 5-year career plan that will build upon her background both in Hematology/Oncology and Hematopathology. Under the co-mentorship of Drs. Scott Armstrong and David Williams, recognized leaders in leukemia, hematopoietic stem cell biology, and translational research, she seeks to utilize a definitive biologically relevant mouse model and pharmacologic approaches to study the role of Hh in leukemogenesis. Dr. Hofmann Zhang will be mentored by an Advisory Committee of internationally recognized experts in the field. Finally, the plan is ideally carried out in the Division of Hematology/Oncology at CHB, given it's distinguished record for training physician-scientists in a rich and collaborative environment.

Public health relevance
PUBLIC HEALTH RELEVANCE: Developmental pathways such as Wnt, Notch, and Hedgehog (Hh) are essential in regulating tissue and organ development during embryogenesis. Furthermore, Hh has been found to be important in certain aspects of hematopoiesis and in tumorgenesis of several types of cancers. Development of Hh antagonists are currently underway as potential therapeutic agents for several solid tumors. Their potential application in the treatment of leukemia remains unclear. The results that will emerge from this proposal will provide novel insights into the role of the Hh signaling pathway in the development and maintenance of leukemia and will inform us about the specific use of Hh antagonists as potential therapeutic agents for specific leukemias. Project Narrative/Relevance Developmental pathways such as Wnt, Notch, and Hedgehog (Hh) are essential in regulating tissue and organ development during embryogenesis. Furthermore, Hh has been found to be important in certain aspects of hematopoiesis and in tumorgenesis of several types of cancers. Development of Hh antagonists are currently underway as potential therapeutic agents for several solid tumors. Their potential application in the treatment of leukemia remains unclear. The results that will emerge from this proposal will provide novel insights into the role of the Hh signaling pathway in the development and maintenance of leukemia and will inform us about the specific use of Hh antagonists as potential therapeutic agents for specific leukemias. __SpecificAimsTextDelimiter__ 4. Research Plan A. Statement of Hypothesis and Specific Aims Hedgehog (Hh) pathway proteins are a highly conserved family of intracellular signaling molecules that are critical for the development of multiple organs, and play a role in cell fate determination of self-renewing tissues in the adult. Multiple studies have explored the role of the Hh pathway in development, and several studies have addressed the role of Hh in the hematopoietic system. Specifically, Hh has been reported to play a role in hemangioblast formation (Deyer et al., 2001); B-cell, T-cell and thymocyte development (El Andaloussi et al., 2006; Outram et al., 2000; Sacedon et al., 2005; Uhmann et al., 2007); erythrocyte proliferation and differentiation (Detmer et al.,2000); and the HSC and progenitor cell compartment (Bhardwaj et al., 2001; Gering et al., 2005; Trowbridge et al.; 2006). Additionally, mutations in the Hh signaling pathway lead to severe developmental abnormalities, and have been associated with several types of cancers including pancreatic adenocarcinoma and small cell lung carcinoma. Based in part on these observations, Hh antagonists are under development as potential therapeutic agents for such cancers (Pasca di Magliano and Hebrok, 2003; Rubin and de Sauvage, 2006). We recently reported the unexpected finding that loss of Hh signaling through conditional deletion of Smoothened (Smo) in the adult hematopoietic compartment has no apparent effect on adult hematopoietic stem cell function and hematopoiesis (Hofmann et al., 2009). Furthermore, pharmacologic inhibition of Hh signaling with a potent and selective small molecule antagonist had no substantive effect on hematopoiesis in the mouse (Hofmann et al., 2009). However, these findings do not discount the possibility that Hh is important in leukemogenesis. Recent reports indicate that conditional deletion of Smo impairs the development of BCR-ABL induced CML in mice (Dierks et al., 2008; Zhao et al., 2009). Given the significant clinical implications we propose to more fully assess the role of Hh in leukemogenesis. It is likely that the Hh pathway plays a critical role in leukemias other than CML and we have carried out initial experiments to test this hypothesis. Interestingly using both in vitro and in vivo assays (Hofmann et al., 2009) we found that the Hh pathway seems to be dispensable for initiation of MLL-AF9 mediated leukemia. Our results suggest that there are allele specific differences in the requirement of Hh signaling in leukemia. We therefore developed the hypothesis that leukemia associated alleles that do not themselves engender self- renewal potential to committed hematopoietic progenitors, such as BCR-ABL or oncogenic KRAS, require Hh signaling for long term disease maintenance. In contrast, we hypothesized that leukemogenic alleles such as MLL-AF9 or CDX2 that can confer properties of self-renewal to committed progenitors do not require Hh signaling. To test this hypothesis we propose to express the respective alleles in a Smo deficient background and assess impact on development, transplantability, and maintenance of leukemia. Complementary to our genetic based experiments we seek to translate our findings into preclinical studies by using a pharmacologic approach to assess whether small molecule Hh antagonists can inhibit leukemogensis derived from the respective alleles. Specific Aim 1: To determine if Hh signal transduction is required for leukemic transformation mediated by oncogenes that that do not confer self-renewal potential such as BCR-ABL, and oncogenic KRAS. We will utilize our already established conditional loss of Smo mouse model to assess if Hh signaling is required for leukemogensis and disease maintenance. We will use retroviral bone marrow transplantation or genetic approaches to express the oncogenes above and determine differences in disease latency, transplantability and maintenance in a Smo deficient background. Furthermore we will perform a comprehensive histopathologic and immunophenotypic characterization of the leukemia phenotype. 1A: Assess whether Hh signaling is required for leukemogensis mediated by KRAS. 1B: Assess whether Hh signaling is required for maintenance of leukemia induced by BCR-ABL. Specific Aim 2: To evaluate whether Hh signaling is dispensable for leukemogenesis mediated by oncogenes that do engender self-renewal potential such as MLL-AF9 and CDX2. In order to compare the results of Specific Aim 1 and 2 we will use retroviral bone marrow transplantation to induce ML-AF9 or CDX2 mediated leukemia. We will perform the same analysis as described in Specific Aim 1. 2A: Assess whether Hh signaling is required for leukemogensis mediated by CDX2. 2B: Assess whether Hh signaling is required for maintenance of leukemia induced by MLL-AF9 and CDX2. Specific Aim 3: To determine whether progression of leukemia induced by BCR-ABL, KRAS or MLL- AF9 can be inhibited by the selective small molecule Hh inhibitor HhAntag in vivo. We will use retroviral bone marrow transplantation techniques (BCR-ABL or MLL-AF9) and genetic approaches (KRAS) and assess whether the Hh inhibitor HhAntag can inhibit leukemia proliferation in mice. Taken together, the findings that will emerge from this proposal will provide novel insights into the role of the Hedgehog signaling pathway in leukemogensis and maintenance of leukemia. The emerging findings will provide critical knowledge for the use of Hh antagonists as potential targets for therapeutic intervention in AML.